Ultrasound for bedside characterization of swallowing biomechanical impairments and biofeedback

Project Summary/Abstract
Older adults are at risk for developing swallowing disorders (dysphagia) due to advancing age coupled with
complicating comorbid diseases. Dysphagia is defined as altered swallow safety (aspiration) and/or efficiency
(residue) and, if undetected and unmonitored, consequences include compromised health status (aspiration
pneumonia, choking) and affected quality of life. Radiologic imaging (videofluoroscopy) is the most
comprehensive and well-studied modality for evaluation. However, clinicians treating patients in non-hospital
settings do not have ready access to this instrumentation. While less comprehensive, ultrasound imaging has
been proposed as a bedside solution that would allow clinicians to monitor specific changes in swallowing
physiology, conduct therapy, and provide evidence for appropriate referral for videofluoroscopic assessment.
However, there is a lack of evidence regarding congruence between ultrasound and videofluoroscopic measures
of swallowing biomechanics (criterion validity) and whether ultrasound can detect clinically salient features of
swallowing. Further, ultrasound imaging for swallowing biofeedback has not been tested in people with
dysphagia. These limitations have prevented clinical translation of this tool. We propose to: (Aim 1) validate
ultrasound measures of oropharyngeal movements vs simultaneous MBSS and determine how these measures
relate to clinical metrics of swallowing function (Modified Barium Swallowing Impairment Profile [MBSImP]
Scoring; Analysis of Swallowing Physiology: Kinematics, Events, and Timing [ASPEKT]); (Aim 2) determine
whether ultrasound biofeedback improves execution of therapeutic swallowing maneuvers in persons with
dysphagia. For Aim 1, we will recruit older individuals (≥60 years, N=70) with neurogenic (e.g. cerebrovascular
accident [CVA]) and neurodegenerative disorders (e.g. Alzheimer’s Disease/Alzheimer’s Disease Related
Dementias [ADRD]) who are referred for a MBSS in our standard-of-care clinic. During MBSS, we will collect
simultaneous ultrasound imaging with the probe placed in various sagittal, coronal, and transverse positions
along the neck to capture lingual, pharyngeal, hyoid, vocal fold, and bolus movements. For both modalities, time-
dependent movements of oropharyngeal structures including displacements, velocities, and relative timing will
be measured. Ultrasound measurements will be validated vs measurements from MBSS imaging and evaluated
relative to clinical metrics of swallowing physiology using MBSImP scoring and ASPEKT. For Aim 2, a subset of
participants (N=44) will be randomly sampled to test whether real-time ultrasound biofeedback improves
performance of therapeutic maneuvers for patients with dysphagia. We will compare ultrasound measurements
of maneuvers completed with and without visual ultrasound biofeedback. This project will lay the groundwork for
future investigations on ultrasound as a point-of-care tool to transform dysphagia diagnosis, monitoring and
treatment at the bedside and in non-hospital settings.

Public health relevance
Project Narrative Older individuals are at increased risk for swallowing impairments (dysphagia), and in many remote care settings (e.g. nursing homes, home health) treating clinicians do not have ready access to fluoroscopic imaging equipment for diagnosis, monitoring, and treatment of swallowing disorders. Ultrasound imaging is a promising option that would allow providers and patients to monitor swallowing movements at the bedside, but validity and reliability of ultrasound use to objectively characterize swallowing has not yet been established. This study will provide essential, fundamental evidence validating ultrasound measurements for characterization of swallowing movements, forming the foundation for future improvements in dysphagia treatment.